Vanderbilt Student Research Training Program

Project Summary
This T35 grant application from the Vanderbilt Student Research and Training Program (SRTP) requests
continued support for medical student research training in the areas of diabetes, obesity, digestive diseases,
and kidney diseases. The Vanderbilt SRTP provides an opportunity for medical students to conduct
intensive, mentored research early in their academic careers (between the first and second years of medical
school). By doing so, this program seeks to expose students to career opportunities in biomedical research
in diabetes, obesity, digestive diseases, and kidney diseases. Participants in the SRTP are chosen from
applicants from US medical schools. The SRTP is affiliated with three Vanderbilt research centers: a NIDDK-
supported center grant in diabetes (P30), a NIDDK-supported center grant in digestive disease (P30), and a
NIDDK-supported center grant in kidney disease (P30, award pending). These three centers provide the
SRTP research base and preceptors for the student’s research experience. The requested number of
student positions in the SRTP (32) is based on Vanderbilt resources (number of available research
laboratories, lecture size, administrative staff) and our experience with this program. During the summer, the
vast majority of the student’s time is spent under the direction of his/her scientific mentor. In addition, student
participants are united on a regular basis for a lecture series on current challenges for research and career
advice. In addition to training and mentoring of more than 153 medical students from 76 US medical schools
in the current funding cycle, the Vanderbilt SRTP has made important contributions to medical student
research training more broadly by facilitating and supporting the a national NIDDK-funded summer research
program for medical students. As judged by a robust SRTP evaluation program, the students’ experiences
were meaningful and impactful, led to subsequent research involvement, and influenced the next steps in
career decisions.

Public health relevance
Narrative This T35 grant application from the Vanderbilt Student Research Training Program (SRTP) requests support for medical student research training in the areas of diabetes, obesity, digestive diseases, and kidney disease. The SRTP is affiliated with three NIDDK-supported Vanderbilt Research Centers: the Vanderbilt Diabetes Research and Training Center (VDRTC), the Vanderbilt Digestive Diseases Research Center (VDDRC), and the Vanderbilt O'Brien Kidney Center (VOKC).